Rab27 in tick extracellular vesicle biogenesis

PROJECT SUMMARY/ABSTRACT
The blacklegged tick, Ixodes scapularis, is the most medically relevant arthropod vector of infectious
disease in the United States. It transmits over six pathogens of

Public health relevance
public health relevance but remains critically understudied. I. scapularis releases a variety of anti-inflammatory, anesthetic and anti-coagulant molecules through its saliva during a blood meal. Recently, it was found that extracellular vesicles (EVs) are secreted in its saliva and may enable microbial transmission to the mammalian host. EV biogenesis and their function have been studied in mammalian systems but its role in arthropods of public health relevance remains elusive. In this F31 application, we report a protein that is putatively critical for tick EV biogenesis and infection. The central hypothesis of this proposal is that Rab27 is involved in tick EV biogenesis. In Aim# 1 of this project, the function and location of Rab27 within tick EV biogenesis will be characterized by utilizing innovative technology previously unavailable in tick cells, including clustered regularly interspaced repeats (CRISPR) and ectopic expression. These approaches will be complemented with subcellular fractionation and an ex vivo tick salivary gland organoid model. In Aim# 2 of this project, the involvement of Rab27 in the infection of the rickettsial agent A. phagocytophilum will be examined. I will employ CRISPR to explore the impact of a Rab27 knockout on bacterial burden in tick cells. Furthermore, I will ectopically express Rab27 to determine if it colocalizes with GFP expressing A. phagocytophilum. I will examine the effect of silencing Rab27 in the tick on A. phagocytophilum transmission and acquisition in vivo. Upon completion, the aims of the proposed research will provide novel insights into non-insect arthropod cellular biology and vector-pathogen interactions.